Pilot/Demographic Clinical Research Project Program

The goal of the BVMC Pilot/Demonstration Projects Program (PPP) is to fund promising projects that take advantage of new clinical research opportunities in rare diseases. Typically, these projects demonstrate feasibility and generate proof-of-concept data for future grant funding and clinical studies. These projects will have potential for high impact to the relevant projects in the BVMC. We will support a minimum of 3 or a maximum of 5 pilot projects (one per year) for the duration of the grant. Aim: To select, fund, and oversee high-quality pilot project proposals relevant for BVMC projects. The Administrative Unit will manage pilot projects, but the BVMC Executive Steering Committee will formulate decisions regarding project funding, taking into consideration clinical research potential in rare diseases, thematic relationship to the aims and scope of the BVMC, quality of the proposal, feasibility in projected time frame, and ability to support promising junior investigators. The Genetics, Statistics and Analysis Core will provide experimental design, genetic and statistical analysis support as needed.

Public health relevance
The BVMC Pilot/Demonstration Projects Program (PPP) is an important avenue for funding promising pilot projects to demonstrate feasibility and generate proof-of-concept of relevance to BVMC projects.